Clinical Center for NICHD/Neonatal Research Network

﻿
DESCRIPTION (provided by applicant): This is an application from the University Of Pennsylvania Perelman School Of Medicine and the Children's Hospital of Philadelphia to continue their participation as a Clinical Center in the Eunice Kennedy Shriver NICHD Cooperative Multicenter Neonatal Research Network (NRN). The NRN performs experimental and observational clinical studies in sick and preterm newborn infants. The goal of the Network is to advance neonatal care and improve long-term outcomes through rigorous evaluation using common protocols.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of the Eunice Kennedy Shriver NICHD Cooperative Multicenter Neonatal Research Network is to advance the field of Neonatal Medicine through sound collaborative clinical research. The Division of Neonatology at the University Of Pennsylvania Perelman School Of Medicine and Children's Hospital of Philadelphia was ranked Number 1 in the USA by US News and World Report and is an ideal clinical center for this Network.